Translation fidelity as a modulator of hematopoietic stem cell fitness and longevity

PROJECT SUMMARY/ABSTRACT
Hematopoietic stem cells (HSCs) give rise to all blood and immune cells throughout life. Aging HSCs exhibit
diminished regenerative function, myeloid-biased differentiation, and clonal outgrowth, which contribute to
compromised immunity and increased incidence of bone marrow (BM) failure, and hematological malignancies
in the aged population. Recent findings demonstrated that HSCs require strict regulation of protein homeostasis
(proteostasis) to maintain self-renewal potential, but this declines with age. Translation is the most error prone
step in gene expression and is a prominent source of proteostasis dysfunction. Previous studies demonstrated
that HSCs depend on lower protein synthesis rates to preserve proteostasis, and increasing protein synthesis
diminishes proteome quality and impairs HSC function. This raises the possibility that HSCs depend on
enhanced translation fidelity, and that increasing fidelity could mitigate age-related changes in proteostasis and
declines in HSC function. Our central hypothesis is that young adult HSCs have higher translation fidelity
compared to restricted progenitors and old adult HSCs, and interventions that enhance translation fidelity will
improve HSC fitness and longevity. To directly test this hypothesis, I generated a fluorescence-based translation
fidelity reporter mouse, and in Aim 1 I will compare translation fidelity in young and old HSCs and progenitors in
vivo. To examine the impact of enhancing fidelity, I generated a mouse model with high-fidelity ribosomes
(Rps23K60R/K60R). Using this model, I will test if enhancing translation fidelity protects HSCs from the proteostasis
disrupting effects associated with increased protein synthesis in a Pten-deficient mouse model in vivo. In Aim 2,
I will test if enhancing translation fidelity improves age-associated declines in HSC function by performing
comprehensive hematopoietic analyses and competitive transplantation assays. I will also determine if
enhancing translation fidelity extends HSC longevity in serial transplantation assays. Finally, I will extend
preliminary RNA-sequencing data to confirm that enhancing translation fidelity promotes improved proteostasis
maintenance in aging HSCs using a suite of single cell assays to quantify misfolded and unfolded protein.
Collectively, these studies will determine if translation fidelity varies across cell types within the blood and is
altered upon aging or in the presence of HSC disrupting pathogenic mutations. Research outcomes will reveal
if modulating translation fidelity is a potential therapeutic strategy to enhance stem cell fitness in older adults.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cells (HSCs) regenerate all blood cells throughout life, but their function declines with age. This proposed research will investigate the role of translation fidelity in promoting protein homeostasis, HSC fitness, and longevity during aging. Investigating the role of translation fidelity in HSC function and longevity is critical for developing new therapeutic targets that mitigate age-associated functional declines of HSCs and to enhance the regenerative capacity of stem cells in older adults.